Electron Transfer in Iron and Copper Oxygenases and Oxidases

Oxygenase and oxidase enzymes must coordinate the delivery of four protons and four electrons to O2 to
prevent the formation of harmful reactive oxygen species. The risks posed by reactive intermediates are so great
that aerobic organisms need mechanisms to protect oxygen-utilizing enzymes from inactivation when primary
electron/proton transfer mechanisms are disrupted. Radical transfer pathways that deliver oxidizing equivalents
(holes) away from frustrated reactive intermediates in enzyme active sites to the protein surface for reaction with
intracellular antioxidants can provide such protection. These radical transfer pathways are constructed from
chains of tryptophan (W), tyrosine (Y), cysteine (C), and possibly methionine (M) residues. This research will
focus on cytochromes P450 (P450) and Streptomyces coelicolor small laccase (SLAC).
The cytochromes P450 are members of a superfamily of heme oxygenases involved in xenobiotic metabolic
and biosynthetic pathways. In mammals these functions include drug metabolism, conversion of lipophilic
molecules to more polar products for enhanced elimination, steroid biosynthesis, and eicosanoid synthesis and
degradation. Cytochromes P450 also are responsible for 66% of enzymatic activation of carcinogens. Elucidating
the mechanisms by which P450s avoid inactivation in the presence of diverse substrates can contribute to
defining therapeutic drug efficacies and mitigating the risks of adverse drug-drug interactions. Chains of W and
Y residues in three bacterial P450s have been characterized for their potential as protective electron transport
conduits. The protective roles of individual amino acids in W/Y chains of the three cytochromes P450 will be
evaluated in measurements of the total number of turnovers before enzyme deactivation. The mechanism of
protection will be elucidated using colorimetric redox indicators bound near the surface termini of W/Y chains.
These indicators will report on the arrival of holes at the end of a W/Y chain in single-turnover stopped-flow
kinetics measurements.
Evidence is emerging from in vitro studies of P. megaterium P450BM3 that hole transport along W/Y chains
can extend the functional life of the enzyme. Research in this program aims to establish whether the extended
P450BM3 survival resulting from these chains provides any measurable advantage to the bacterium. Preliminary
studies of a P450BM3 deletion mutant of P. megaterium have identified a phenotype attributable to the enzyme.
Investigations of wild-type and mutant P. megaterium strains aim to determine whether disruption of W/Y chains
negatively impacts growth of the organism.
The multicopper oxidase SLAC and human ceruloplasmin are structurally homologous enzymes in which a
Tyr radical forms during catalysis. SLAC will be used as a surrogate for ceruloplasmin, owing to its efficient
heterologous expression in E. coli. Measurements of the total number of turnovers in wild-type and mutant
enzymes aim to elucidate the roles of W and Y radicals in SLAC catalysis.

Public health relevance
Aerobic organisms utilize the oxidizing power of molecular oxygen but must avoid the harmful effects of partially reduced oxygen species. Organisms that utilize oxygen have developed mechanisms to protect oxygenases and oxidases from damage in the event of unsuccessful substrate reactions. Pathways composed of tryptophan and tyrosine residues provide that protection by guiding potentially damaging oxidants to enzyme surfaces for reaction with external reductants.